The role of area V4 in the perception and recognition of visual objects

In natural vision, retinal stimulation is ever-changing due to saccades and observer motion, but our percept of
the world remains remarkably stable. How this is achieved is a major unsolved mystery in systems
neuroscience. Prior neurophysiological and psychophysical studies have identified three hypothetical encoding
strategies that may contribute to visual perceptual stability in the primate brain. First, neuronal representations
may carry a prospective code of what is expected to occupy the future receptive fields of neurons even before
our eyes land on the saccade target. Second, salient visual objects may be represented in terms of a
spatiotopic code, i.e. in world-coordinates (in addition to retinal coordinates), which could provide a perceptual
anchor even as the retinal representations shift. Third, neuronal representations may be hysteretic, with
responses depending not just on the current retinal image but also on the recent past. These three strategies
may operate in parallel across a network of cortical and subcortical brain regions to achieve stability. In this
grant cycle, we will investigate the contributions of area V4, a midlevel processing stage in the ventral visual
stream that is critical for form encoding and scene perception and is heavily interconnected with parietal,
frontal and subcortical brain regions. Using a combination of fixation and naturalistic behavioral paradigms,
immersive visual displays of objects, textures and scenes, and recordings with high-density Neuropixels
probes in the awake macaque monkey, we will investigate whether: (Aim 1) V4 neurons carry prospective
signals that are comprehensive in terms of feature selectivity, spatial coverage and precision, to provide
complete and precise trans-saccadic integration, (Aim 2) visual object representations in V4 are modulated by
gaze position akin to parietal gain fields, thereby providing an implicit representation in a spatiotopic reference
frame at the population level, and, (Aim 3) V4 responses to continuously changing stimuli (mimicking self-
motion) are hysteretic, i.e. responses change more slowly than the stimulus itself, thereby providing a neuronal
basis for stable perception during observer motion. Our results will: (i) support the development of new models
of midlevel cortical representations as a function of extraretinal inputs and current, future and past retinal
stimulation, (ii) delineate a framework of representational ebb and flow as animals saccade from one location
to the next in the visual world, (iii) provide insights into the neurophysiological basis for myriad psychophysical
results that have revealed how visual stimuli are integrated, what frames of reference (retinotopic vs
spatiotopic) are relevant and whether and how stimulus history contributes to object invariance and continuity
across saccades. Parallel experiments in area V2 will provide insights into how V4 representations may be
built. More broadly, the encoding models developed here based on controlled, rigorous characterizations, will
provide a critical framework for interpretation in future studies of naturalistic visual explorations in the
macaque, a growing direction for systems neuroscience research.

Public health relevance
NARRATIVE Using fixation and naturalistic behavioral paradigms, immersive visual displays of objects, textures and scenes, and recordings with high-density neuropixels probes in the awake macaque monkey, we will achieve a new level of understanding about how visual representations in midlevel stages of the ventral visual stream support perceptual stability even as retinal stimulation changes continuously due to saccades and observer motion. These findings will ultimately bring us closer to devising strategies to alleviate and treat brain disorders of impaired object recognition resulting from dysfunctions in the occipito-temporal pathway (e.g. agnosia).